Evaluating the Comparative Validity and Reliability of SERAS: A Decision Support Tool for Assessing Near Term Risk of Suicide in Emergency Departments.

PROJECT SUMMARY
Every day more people commit suicide than die from motor vehicle accidents in the US. The goal of the NIMH
Zero Suicide Initiative is prevention of suicide among those being served by health care systems. The Joint
Commission has mandated that hospitals reduce suicide in healthcare settings through the use of evidence-
based screening and assessment. An essential element of this process is the development of rapid but effective
evidence-based screeners for use in emergency rooms, crisis clinics, and other first responder facilities. Our
Systematic Expert Risk Assessment of Suicide (SERAS™) is a neural-network-based decision support tool that
replicates the critical thinking of experienced clinicians in weighing risk factors to prospectively assess an
individual's near-term risk of suicide. Our Phase I project demonstrated that SERAS™ provides the same
concurrent and predictive validity as a full clinician-based Columbia Suicide Severity Rating Scale (CSSRS)
when used in an emergency department setting, yet takes a fraction of the time. We have two goals in this Phase
II application. Our first goal is to integrate SERASTM into the workflow of a new healthcare system electronic
health record and to establish its acceptability and usability when it replaces current standard screeners. We
expect that SERASTM will have good-to-excellent usability and will be readily accepted as being easy to use and
useful. Our second goal is to move SERAS™ to a large scale, full implementation across a healthcare system
and pairing it with in-person or telehealth secondary assessments for those who screen at low to moderate risk.
By implementing SERAS™ into the standard clinical workflow of 4 hospitals out of a 20 hospital system in the
Omaha, Nebraska region, and screening more than 100,000 adults with SERAS™ we will examine whether
there is a reduction in the incidence of suicide and suicide-related events in this system over a two-year period.
This project, when complete will enable timely care; it will implement efficient and less costly healthcare delivery;
it will enhance surveillance of individuals at risk within the healthcare system; and it will provide immediate
decision support to the end user by identifying targeted interventions. We provide evidence for the commercial
potential of SERAS™ through a detailed commercialization plan that demonstrates that, even with relatively low
levels of market penetration, this tool can become self-sustaining to allow for more evidence-based screens and
more lives saved.

Public health relevance
PROJECT NARRATIVE Every day more people commit suicide than die from motor vehicle accidents in the US. Using a newly validated evidence-based screening tool for near-term suicide risk called SERAS™ we demonstrate that we can integrate this system into the workflow of a busy healthcare system and find it to be acceptable and usable. We will then test whether SERASTM, when coupled with evidence-based assessment either in person or via telehealth, will reduce suicide-related events in over 100,000 people screened over a two-year time frame.